EFFECTS OF ESTROGEN REPLACEMENT ON INTERLEUKIN 6 PLASMA LEVELS

The objective of this study is to establish the normal circadian variation of circulating interleukin-6 (IL-6) in healthy postmenopausal women, and to assess the effect of estrogen replacement therapy on the circadian structure of IL-6.